Role of FBXO45 in Diffuse Large B Cell Lymphoma Pathogenesis

PROJECT SUMMARY
THE ROLE OF FBXO45 IN DIFFUSE LARGE B-CELL LYMPHOMA PATHOGENESIS
Diffuse large B-cell lymphoma (DLBCL) is an aggressive lymphoma and represents the
most common form of malignant lymphoma in the western hemisphere. The biologic events
underlying the pathogenesis of DLBCL are not completely understood. We have recently
identified functional inactivation of FBXO45, an E3 ubiquitin ligase in DLBCL. In this
application, we will utilize transgenic mouse models to explore the biological roles for
FBXO45 in B-cell differentiation and lymphomagenesis. Further, we will employ
biochemical and molecular biology techniques to better understand the role FBXO45 in the
pathogenesis of DLBCL. Accordingly, we propose in the first aim of this application to utilize
newly created transgenic mouse models to functionally interrogate the role of FBXO45 in B-
cell development and lymphomagenesis. In the second aim, we will identify the global
cellular substrates of FBXO45 in B cell contexts. These studies will establish the role of
FBXO45 in the pathogenesis of DLBCL and establish the mechanisms by which its
deregulation contributes to DLBCL.

Public health relevance
Project narrative Deregulation of ubiquitin ligases and their substrates is increasingly being recognized to play a significant role in the pathogenesis of cancer. In this proposal, we will investigate the involvement of a ubiquitin ligase known as FBXO45 in the development of diffuse large B-cell lymphoma, the most frequent form of lymphoma death in the U.S. Our studies will lead to a better understanding of the function of FBXO45 and offer insights into novel therapeutic strategies for treatments of DLBCL.